CardioPulmonary Vascular Biology COBRE

The vision of the CardioPulmonary Vascular Biology Center of Biomedical Research Excellence (CPVB
COBRE) is to advance understanding of vascular diseases affecting the pulmonary and cardiovascular
systems. This vision will be accomplished through research performed by a multidisciplinary group of
outstanding investigators who are using cutting edge tools to understand the pathobiology of vascular
diseases. In this phase II application we seek to renew funding for a second 5 years. We will continue the
research partnership of three collaborating institutions—Ocean State Research Institute (OSRI), the Rhode
Island Hospital, and Brown University. The applicant institution, OSRI, is the research and education nonprofit
associated with the Providence VA Medical Center, a teaching hospital affiliated with the Warren Alpert
Medical School of Brown University. In Phase I, the CPVB COBRE supported development of a community of
researchers, provided career development and research skill training, and stimulated new research
collaborations among the investigators, mentors, and other faculty. Strong institutional support brought expert
visitors to the center, resulting in additional research collaborations. Teaching and mentoring activities of
CPVB COBRE investigators enhanced knowledge of vascular biology among undergraduate and graduate
students, as well as postdoctoral trainees and junior faculty. CPVB COBRE investigators have competed
successfully for $7.61 million in research funding during Phase I. Similar approaches will be used during Phase
II, and five outstanding junior investigators have been identified who bring complementary backgrounds, skills,
and research interests. New areas of research will be pursued using innovative approaches that expand the
scope of COBRE technical resources. Thus, the CPVB COBRE will continue to broaden the scope and depth
of vascular biology research at the partnering Rhode Island institutions. The CardioPulmonary Vascular
Biology COBRE proposes the following specific aims for Phase II of funding: (1) Create a multidisciplinary
group of investigators in studies of vascular injury and repair. (2) Provide research support, protected time,
and mentoring to enable junior investigators to become independent scientists and provide robust support for
research career and professional development. (3) Expand the CardioPulmonary Vascular Biology Center into
new research areas and thereby enhance and broaden vascular biology research at collaborating institutions.
(4) Provide services supporting vascular biology research and develop a self-sustaining Cell/Organ Core.
Accomplishment of these aims will result in a strengthened and broadened CardioPulmonary Vascular Biology
COBRE that will be the basis for new interdisciplinary scientific collaborations, significant contributions to
understanding of pulmonary and cardiovascular diseases, and improvements in the health of the citizens of
Rhode Island and the nation.

Public health relevance
The vision of the CardioPulmonary Vascular Biology Center of Biomedical Research Excellence (CPVB COBRE) is to advance understanding of diseases of the blood vessels. This vision will be accomplished through research of a group of outstanding investigators who are using cutting edge tools to understand diseases of the blood vessels. The CardioPulmonary Vascular Biology COBRE will be strengthened and broadened and will provide the basis for new scientific collaborations, important contributions to understanding of blood vessel diseases, and improvements in the health of the citizens of Rhode Island and the nation.